South Carolina Cancer Disparities Research Center (SC CaDRe)

SC CADRE 1U54CA210963-01A1
Bridge Funding
SUMMARY This five-year U54 proposal is a collaborative, inter-institutional partnership
between South Carolina State University (SCSU), an Historically Black University (HBCU), and
the Medical University of South Carolina Hollings Cancer Center (MUSC-HCC), a National
Cancer Institute-designated cancer center. The partnership began in 2011 under the auspices of an
NCI P20 CPACHE grant and has grown to produce this U54 South Carolina Cancer Disparities
Research Center (SC CADRE) application. With input from their joint community partner, the
Regional Medical Center of Orangeburg Mabry Cancer Center (RMC-MCC), investigators at both
institutions collaborated to design the SC CADRE. The overarching goals of the SC CADRE are
to increase SCSU’s capacity to conduct transdisciplinary cancer research and to further strengthen
and extend a longitudinal research education pipeline that will catalyze a new diverse generation of
biomedical researchers focused on cancer disparities. The SC CADRE has three major themes.
The first focuses on evaluating the relationship between obesity and prostate and breast cancer
disparities. The second theme emphasizes evaluation of advanced glycation endproducts (AGEs)
as a novel biomarker related to cancer, cancer disparities, and obesity. The third theme highlights
the inclusion of a population unique to the US southeastern coastal region, the Sea Island
(SI)/Gullah population. Within five years, the SC CADRE aims for: 1) further elucidation of
molecular mechanisms contributing to cancer disparities; 2) an enhanced pipeline of diverse
cancer researchers; 3) an increased number of NIH research proposals led by SCSU faculty as
independent investigators; and 4) greater community engagement in cancer research. Due to the
longstanding SCSU /MUSC-HCC academic partnership and each entity’s research and
educational strengths and community relationships, the SC CADRE is poised to transform cancer
health outcomes for South Carolinians

Public health relevance
SC CADRE 1U54CA210963-01A1 Bridge Funding Project Narrative The South Carolina Cancer Disparities Research Center is an inter-institutional partnership between South Carolina State University (SCSU) and the Medical University of South Carolina Hollings Cancer Center. Incorporating community engagement, these two institutions will build a lasting, sustainable, translational cancer research structure at SCSU and further strengthen a research education pipeline that will catalyze a new diverse generation of cancer researchers.